Epigenetic Control of CD8 T-Cell Differentiation in Human Lymph Nodes

PROJECT SUMMARY
The development of potent antiretroviral therapies, now delivered as a single pill once a day, has transformed
HIV infection into a chronic disease. Globally, over 19 million people are now on life-long treatment, and test-
and-treat strategies as was well as oral PrEP have the ability to further reduce HIV transmissions. However,
despite these remarkable advances, prolonged ART mediated suppression of plasma viral loads to undetectable
levels does not eradicate the virus, which rapidly rebounds upon treatment interruption. The many logistical
limitations and cost challenges that come with providing life-long care to those living with HIV highlights the need
for novel strategies of controlling the virus in the absence of therapy. Emerging data indicate that lymph nodes
are a major source of HIV persistence during ART mainly because infected T follicular helper cells are protected
from immune elimination due to partial exclusion of cytotoxic CD8 T cells (CTL) from germinal centers (GC). The
molecular mechanisms that regulate CXCR5 expression which allows CTL migration into GCs are not known,
mainly due to the difficulty associated with obtaining lymph node samples for such studies. Through innovative
recruitment strategies, we have now solved this problem. We propose to use stored lymph node samples
obtained from persons identified and treated at the onset of plasma viremia, in many when plasma viral loads
are less than 1,000 RNA copies/ml to investigate why CTLs are largely excluded from GCs. Our preliminary
ATAC-Seq studies suggest that CXCR5 expression on lymph node CTLs is epigenetically regulated. To follow
up on this observation we propose to conduct chromatin accessibility analysis and transcriptional profiling of
sorted HIV-specific CD8 T cells to identify epigenetic mechanisms that regulate CXCR5 expression. Our
experimental approach will involve pairwise chromatin accessibility and transcription analysis of sorted follicular
and extrafollicular HIV-specific CD8 T cells. This strategy will help to identify novel epigenetic and transcription
factors that are different between the two populations. Finally, we will manipulate some of the differentially
expressed genes using exogenous agents namely cytokines and epigenetic modifying drugs to determine the
optimal conditions to induce CXCR5 expression on CD8 T cells. Our results will lead to novel strategies for
redirecting CTL to follicular areas where they are needed to kill HIV infected cells. If successful, our studies will
lead to novel strategies for redirecting CTL to follicular areas to eradicate HIV infection as part of a cure strategy.

Public health relevance
PROJECT NARRATIVE South Africa bears the greatest brunt of the HIV epidemic and has the largest number of people on antiretroviral therapy. The ultimate solution for the people on lifelong therapy is to find a cure. This study seeks to address the major obstacle to HIV cure by identifying means of enhancing immune responses in tissues where HIV tend to hide to evade detection and elimination by the immune system. If successful, this study will lead to new approaches for achieving an immune-mediated HIV cure.